STRUCTURE OF DEHYDROGENASES AND OTHER PROTEINS

The amino acid sequences of the cytoplasmic and mitochondrial forms of pig heart malate dehydrogenase (MDH) as well as beta-hydroxyacyl CoA dehydrogenase (beta HADH) will be used to interpret the electron density maps determined by x-ray crystallography. Analyses will focus on determinants of folding, particularly in regions of similar conformation but highly dissimilar sequences. Lactate dehydrogenase will be included comparatively. The solution conformation of all of these enzymes will be compared to the x-ray derived model by various topographical probes. The biosynthesis of both MDH isozymes and beta HADH will be studied in cell-free systems and the structure of any additional segments found as amino or carboxyl terminal extensions will be sequenced by the incorporation of radiolabelled amino acids. The processing of these molecules will be examined relative to the enzyme(s) responsible. E. coli MDH, as an example of a prokaryotic version of the enzyme, will be isolated, characterized and sequenced and the structure compared to the eukaryotic forms. The translocators for L-malate and alpha-ketoglutarate from pig heart mitochondria will be solubilized by non-ionic detergents and purified by affinity chromatography. Several binding assays will be developed to identify the molecule. Characterization and sequence analysis will be performed on in the isolated translocator. The sequence of 17 beta-estradiol dehydrogenase will be sequenced and compared to the other dehydrogenases under study. In other studies, 1) various defined mutants of E. coli alkaline phosphatase will be isolated and defined in terms of the replacement. Crystals will be prepared and x-ray analysis performed (as difference maps with native enzyme) to correlate changes in three-dimensional structure with changes in kinetic/catalytic behavior. 2) The three-dimensional structure of E. coli biotin carboxyl carrier protein (9100) will be determined. 3) The sequences of chicken intestinal and liver lectins and muscle phosphoglycerate mutase will be determined.